Core C - Neuroimaging and Informatics

CORE C – PROJECT SUMMARY/ ABSTRACT
Sophisticated informatics is critical to the success of any multisite or coordinated scientific effort and
enables subsequent re-use of data and findings in unanticipated ways greatly enhancing the overall value of the
project. Core C of the proposed P01 “Vascular Contributions To Dementia And Genetic Risk Factors For
Alzheimer’s Disease” will continue providing high quality computational, harmonization, and imaging resources
for Projects 1, 2, and 3, Core B, and all P01 investigators, staff, and authorized scientists. The activities of Core
C will support the scientific goals of the P01 as well as the broader national Alzheimer’s disease (AD) and
dementia research community.
Given the multimodality nature of data collected as a part of the P01, robust informatics, data
management, and harmonization are critical. Core C will 1) provide an informatics data management framework
for Projects 1 and 2 including diagnostic criteria for subtle cognitive decline during preclinical and mild cognitive
impairment stages of AD, and harmonized imaging data for all P01 Projects. This centralized web-based data
system will be used for registration and documentation of participants, including enrollment at baseline and
follow-up, archival and tracking of raw and pre-processed imaging data and open data dissemination; 2) ensure
high quality control of all neuroimaging data across P01 Projects using a state-of-the-art workflow for the review
and assessment of diffusion tensor imaging (DTI), functional MRI (fMRI), structural magnetic resonance imaging
(MRI), dynamic contrast-enhanced (DCE) MRI, arterial spin labeling (ASL) MRI, and dynamic susceptibility
contrast (DSC) MRI data; 3) deliver a harmonized analysis workflow for each imaging modality for each Project
that can accommodate any computational environment via a user-friendly, uniform data analysis pipeline that is
accessible to all investigators; and 4) provide biostatistical support (by working with Core A MPIs, all P01 project
and core leaders and co-investigators, and biostatisticians) for our analytic approaches, data harmonization, and
modeling of longitudinal data.

Public health relevance
Project Narrative: Not required per funding opportunity instructions.